Administrative Core

Abstract
The Administrative Core of the University of North Carolina Intellectual and Developmental Disabilities
Research Center (IDDRC) serves as the nucleus of the IDDRC and provides scientific and administrative
leadership. The overarching goal of the administrative core is to create an environment in which science
relevant to discovery of the causes, consequences, mechanisms and treatments of IDD can be effectively and
efficiently designed, conducted and disseminated. The administrative core has the following objectives: (1) to
provide high quality, scientific leadership and an environment that produces the best possible research
relevant to IDDs through (a) developing superior core facilities that best meet the needs of investigators; (b)
recruiting and supporting outstanding investigators, including investigators new to IDD research, and trainnees
who share the IDDRC mission to improve the lives of individuals with IDDs through the conduct of cutting-edge
research on the causes, consequences, mechanisms and treatments of these conditions; (c) serving as liaison
to other university and outside organizations, including NIH, the IDDRC network and, relevant IDD training
programs at UNC, the community; and, (d) promoting a cohesive, integrated IDDRC to maximize the combined
efforts of our investigators and resources in IDD research leading to – ‘a whole greater than the sum of its
parts’; and (2) providing outstanding administrative leadership with respect to managing day-to-day operations
and maintaining high-quality, cost-effective services throughout the center. The services the administrative
core promotes include: (a) development of high-quality core facilities; (b) recruitment and support of
investigators, (c) promotion of a cohesive, integrated, interdisciplinary research center; (d) administrative
services to research projects and investigators; (e) quality assurance of core services; (f) information
technology, audio/visual support, and website management; (g) communication and dissemination; (h) training
and education; and (i) under-represented minority outreach, education, and dissemination.
1